Moving beyond the Pain-Suicidality Link: An Investigation of Fluctuations in Social Threat and Neural Response to Social Threat in Momentary Pain and Proximal Risk for Suicidal Ideation in Adolescence

PROJECT SUMMARY/ABSTRACT
Suicide rates are the second leading cause of death in adolescence. Suicidal ideation (SI) typically develops
in adolescence. The onset of SI is a developmental inflection point associated with pathways toward
persistent and worsening SI and other self-injurious thoughts and behaviors. SI is also associated with
significant health care costs, morbidity, and risk for mortality. Rates of physical pain increase in adolescence
alongside the developmental increase in suicide risk. The presence of physical pain is associated with a 2- to
3-fold increase in SI risk, prompting several major organizations (e.g., World Health Organization, American
Psychiatric Association, and American Foundation for Suicide Prevention) to highlight physical pain
conditions as a serious risk factor for suicide in adults and children ages 10 years and older. Multiple suicide
theories posit that suicidal thoughts and behaviors arise from the desire to escape unbearable pain, including
physical pain. However, research on the pain–suicidality link has heavily relied on cross-sectional studies
focusing on pain diagnoses (e.g., chronic pain) as a single risk factor. Yet, most individuals with a pain
diagnosis do not have SI. There is a need for longitudinal studies investigating how multiple risk factors work
together to influence SI. There is also a need to identify proximal risk for SI (e.g., over hours) given that SI
often fluctuates rapidly over short periods. We will move beyond the pain–suicidality link by investigating
factors that may influence dynamic changes in physical pain and proximal risk for SI among adolescents. We
will investigate the effects of short-term effect of social threat (threat to social status or relationships)
and individual differences in neural response to social threat on momentary increases in physical pain and
proximal risk for SI. We focus on social threat because this is an especially developmentally salient type of
threat in adolescence and has been shown to influence pain. Social threat, like physical threat, also activates
pain-related brain regions involved in a “neural alarm system” to warn against danger. Social threat is also a
robust longitudinal predictor of SI in adolescence. To address major gaps in knowledge of the role of social
threat in the pain–suicidality link, we will test components of an overarching model positing that exposure to
social threat predicts momentary increases in pain (particularly pain unpleasantness). Pain in turn is
a proximal predictor of SI. Heightened neural activation in pain-related brain regions to social threat
amplifies pain and risk for SI in the moments when social threat occurs. We will conduct a longitudinal
study of 200 youth ages 14–17 with recurrent musculoskeletal pain in limbs, back, or neck, which is common
in adolescents and associated with suicide risk. We will recruit youth with a range of pain severity, but will
oversample for high levels of pain to enrich for risk for SI. At baseline, youth will complete fMRI tasks to
measure neural response to social threat. Youth will also participate in ecological momentary assessments
of real-world fluctuations in social threat, pain, and SI over hours.

Public health relevance
PROJECT NARRATIVE Findings will advance understanding beyond the pain–suicidality link by pinpointing (a) proximal factors predicting when suicidal ideation (SI) occurs (i.e., in moments of social threat or physical pain), (b) neural vulnerability markers identifying who develops SI, and (c) how SI may develop through interactions between negative social environments and altered function in the pain system. Findings will inform novel targets for just- in-time interventions that deliver skills through electronic devices in critical moments of risk. Additionally, findings may help refine or augment other existing interventions for SI among vulnerable youth by integrating treatment components that target physical pain in the context of social threat, such as cognitive-behavioral therapies established for pain, or non-invasive fMRI real-time neurofeedback in which youth learn to regulate brain activation in key pain-related brain regions.